Enrichment Program

PROJECT SUMMARY/ABSTRACT – Enrichment Program
The Enrichment Program provides an organizational framework in which an eclectic set of activities works
together to bring added value to a training experience so that the whole is truly greater than the sum of its
parts. The set of activities that constitutes this CCEH Enrichment Program includes 1) expert outside speakers
who not only give a lecture to the larger Hutch community, but also spend an evening with “Fellows only” to
discuss career paths, 2) training opportunities made available by technical experts who staff our cores, 3)
scheduled short presentations of lab-based faculty who are amenable to taking a fellow, and 4) travel support
to obtain specific training at another CCEH site. Added to these is the retention of the internal Pilot & Feasibility
(P&F) program which was at one point a separate program in the CCEH but is now replaced by the External
P&F which will be administered by the soon to be formed coordinating center. Since our P&F grants program
proved valuable to our trainees, we will retain it as part of our enrichment program and fund it from our
Program income account. Finally, we offer to our trainees the opportunity to teach, be a role model and change
the life of an underserved, underrepresented student intern. It is a gratifying experience, made valuable by the
fact that these students lives really do change. Over the last year 25+ student alumni from our summer high
school internship program (SHIP) secured part time lab jobs while attending the University of Washington.